Intravitreal Inj of Ranibizumab for Macular Telangiectasia w/o Neovascularization

Pilot Study of Intravitreal Injection of Ranibizumab for Macular Telangiectasia without Neovascularization (MACTEL 2) his study will examine whether the drug ranibizumab (Lucentis) can help prevent vision loss in people with macular telangiectasia, a condition in which new blood vessels grow in the retina at the back of the eye and can leak. Such changes in blood vessels are seen in other diseases associated with changes in a body chemical called vascular endothelial growth factor (VEGF). Ranibizumab is an anti-VEGF drug that is effective in treating another eye disease, age-related macular degeneration, with similar changes in eye blood vessels.